OBTAIN TISSUES AND ORGANS FROM HIV INFECTED DONORS

This subproject is one of many research subprojects utilizing the resources provided by a Center grant funded by NIH/NCRR. The subproject and investigator (PI) may have received primary funding from another NIH source, and thus could be represented in other CRISP entries. The institution listed is for the Center, which is not necessarily the institution for the investigator. In addition, HTOR will continue a specialized program for procuring and distributing HIV positive tissues (Specific Aim 4), a goal that is also consistent with HTOR's long-term objective.